CT Perfusion to Predict Response to Recanalization in Ischemic Stroke Project 2 (CRISP 2)

Project Summary
Stroke is the number 1 cause of disability in the United States and a global public health problem. Globally,
approximately 15 million people suffer a stroke each year, leading to 5 million deaths and another 5 million
patients who suffer permanent disability from their stroke. Strokes that are caused by blockage of large blood
vessels supplying blood to the brain are typically the most disabling. Over the last 5 years, there have been
major breakthroughs in acute stroke therapy for this type of stroke. In 2015, multiple trials demonstrated a
profound benefit from endovascular stroke therapy for patients with a large vessel ischemic stroke who present
in the early time-window (within 6 hours after symptom onset). This success was followed by the DEFUSE 3
and DAWN trials showing a very strong benefit from endovascular therapy in the delayed time-window (6-24
hours after symptom onset). These therapies have now become standard of care at specialty hospitals
(comprehensive stroke centers) across the country. Despite this new highly effective therapy, stroke-related
disability continues to be substantial for patients with large-vessel occlusions, because of brain damage that
occurs in the time-period before patients receive endovascular therapy that restores blood flow to the brain. The
time period before blood flow is restored can be long (several hours) especially if patients need to be transferred
from a community hospital that does not have the capability to provide endovascular therapy to a comprehensive
stroke center that does. Because of this delay, significant brain damage can occur between the time that a patient
initially presents to a hospital and the time that blood flow is restored. To address this problem, we need to
conduct clinical trials of therapies that protect the brain in the crucial time-period before blood flow is restored.
In order to conduct such trials, we first need tools to identify patients who are most likely to benefit from
treatments that protect the brain and tools that can be used to determine if the treatments are effective. The
overall aim of this project is to develop these tools. We will achieve this aim using both an existing imaging
dataset and using new data that we will obtain from patients who are being transferred from a community hospital
to a comprehensive stroke center for endovascular therapy. To identify patients who will likely benefit from
treatments that protect the brain, we will develop a CT-based tool that visualizes how much brain damage a
patient is likely to sustain during transport. To be able to determine if a treatment is effective at protecting the
brain, we will develop a CT-based tool that can accurately measure the amount of brain damage (infarct volume)
that is already present prior to transport.

Public health relevance
Project Narrative To reduce the public health burden of stroke, the number one cause of disability in the United States, we need treatments to protect the brain in the crucial time-period before blood flow to the brain can be restored. In order to test treatments that protect the brain in clinical trials, we need methods to identify patients who are most likely to benefit from them and methods to determine if the treatments are effective. In this project, we will develop both.